Implementation Science and Equity

PROJECT SUMMARY/ABSTRACT: OVERALL COBRE on Implementation Science & Equity
Shrinking the time lag for translating research evidence into clinical practice would improve health outcomes
across multiple domains and reduce costs to society. Until recently, however, clinical research has devoted
little attention to implementing evidence-based practices in real-world clinical care. Moreover, rural, minority,
and other subpopulations experience even greater gaps in health care quality. Implementation Science is an
emerging field of research that specifically focuses on identifying the best approaches to integrating evidence-
based practices into routine clinical care. Our proposal for a Phase I Center of Biomedical Research
Excellence (COBRE) on Implementation Science and Equity seeks to establish a research center at the
University of Kansas Medical Center (KUMC). This COBRE will develop and test Implementation Science
approaches designed to achieve equitable care for rural, minority, and other underserved populations.
The goal of this multidisciplinary research center in an Institutional Development Award (IDeA) state is to
develop sustainable and generalizable approaches to reducing inequities in care. The Administrative Core
includes an internal advisory committee, an external advisory committee, strong institutional support, and
substantial financial and in-kind contributions from all schools and major centers across KUMC. The proposed
COBRE will consist of three research cores, which will provide unique services for building institutional
capacity in implementation science and will mentor five promising junior project leaders. Our overall specific
aims are to:
Aim 1. Create and sustain an organizational structure to provide scientific mentoring and institutional
support for implementation science and equity at KUMC.
Aim 2. Provide core infrastructure in methodology, engagement, and ethical issues in research with
human subjects, to support implementation research conducted by Project Leaders and the broader
KUMC community.
Aim 3. Select and train outstanding, multi-disciplinary, senior and early-career faculty who will develop
implementation science approaches for delivering high-quality care to underserved groups.
The proposed COBRE will advance the field of implementation science by creating approaches to identifying
inequities, diagnosing causes, and testing solutions. Implementation Science and Equity COBRE leads, Drs.
Kimber Richter and Christie Befort have strong track records in leadership, administration, and mentoring in
implementation science—especially with minority investigators—to achieve research independence. Taken
together, the proposed COBRE will create a sustainable and growth-oriented program in implementation
science that will have local, national, and international impact.

Public health relevance
PROJECT SUMMARY/ABSTRACT: OVERALL COBRE on Implementation Science & Equity Gaps between evidence-based and clinical practice are far greater in the delivery of care to vulnerable subgroups, leading to health and treatment disparities. It is critical to accelerate the adoption of evidence- based practices into healthcare, and Implementation Science is the emerging field that aims to do so. This COBRE will provide mentoring and support to build the Implementation Science and Equity research workforce across our institution, with the goal of ensuring that all Americans receive care that is guided by current professional knowledge and is designed to achieve the best outcomes possible.